Outreach and Dissmination

The proposed CTO's Outreach and Dissemination Unit will be led by Apostolia Maria Tsimberidou, M.D.,Ph.D., the proposed Director of Clinical Translation, Education and Outreach, under the guidance of Jason Sakamoto, Ph.D. the proposed CTO Center Manager. Dr. Tsimberidou is an Assistant Professor at MDACC, Department of Investigational Cancer Therapeutics, a Phase I Clinical Trials Program. Dr Sakamoto Is the Chief Operating Officer of the Alliance for NanoHealth (ANH). He will bring to these units his expertise and the already established infrastructure of ANH, including program management, website development and maintenance, pilot and training project development and outreach programs to assist the Outreach and Dissemination Unit. The Outreach and Dissemination Unit will implement initiatives to support the following aims: 1) Disseminate and increase awareness of concepts, capabilities, and results of PS-OC to physical sciences and cancer research communities;and 2) Provide a mechanism to bridge and develop external collaborations. The Outreach and Dissemination aims will be achieved via the following Initiatives: 1. Virtual seminars;2. Workshops with focus topic of Transport OncoPhysics;3. Virtual networking through Interactive websites;and 4. External Pilot projects.